Sex differences in fast-spiking interneurons promote AUD-related PFC dysfunction: remediation by modulating mGlu1 and mGlu5 - Supplement Rev

Project Summary
We are requesting administrative supplement PA-20-272; NOT-OD-20-055: “Notice of Special Interest (NOSI):
Administrative Supplement for Continuity of Biomedical and Behavioral Research Among First-Time Recipients
of NIH Research Project Grant Awards.” The supplement is requested due to a critical life event for the PI, the
birth of his second child. Additional funds are needed to support a part-time postdoctoral associate who will
perform the whole-cell patch-clamp electrophysiology experiments, analyze data, and disseminate study
findings via manuscripts and conferences presentations. This associate will be essential in returning our lab to
our expected levels of productivity following the PI’s critical life event.
No Change to Original Aims:
Aim 1 (K99): To test the hypothesis that mGlu1 and mGlu5 modulation can ameliorate sex-specific alcohol-
induced pathophysiology through actions on PFC PV-INs. PV-IN synaptic physiology and plasticity will be
interrogated in an ex vivo slice preparation. In addition, PV-IN function will be examined in vivo with fiber
photometry while female and male mice seek alcohol and perform other PFC-dependent behaviors.
Aim 2 (R00): To test the hypothesis that sex-specific alcohol-induced dysregulation of distinct PFC outputs can
be remediated through mGlu1 and mGlu5 modulation of inhibitory transmission. A viral approach will be used to
label PFC pyramidal cells based on projection target in female and male transgenic optogenetic mice (PV-
ChR2). We will assess how PV-INs control specific PFC output pathways following intermittent alcohol
exposure, and how these phenomena are regulated by sex and mGlu1/mGlu5.

Public health relevance
Project Narrative - no change from original Men and women both suffer from Alcohol Use Disorder (AUD), however the disease affects them differently, in part through distinct neurobiological changes in the prefrontal cortex (PFC). This proposal is designed to test the hypothesis that sex differences in drinking are mediated by metabotropic glutamate (mGlu) receptors on specific neuron populations in the PFC. Results from these studies will enhance our understanding of the neurobiology underlying behavioral sex differences related to alcohol and will aid in efforts to develop mGlu receptor modulators as novel medications to treat AUD.